Multipoint contact pressure for haptic sensory prostheses

PROJECT SUMMARY
The human sense of touch plays a crucial role in our perceptual experiences and enabling motor tasks.
Amputation, diabetes, stroke, and a host of other diseases result in loss of touch sensation, affecting modalities
including vibration, skin deformation, proprioception, temperature, and pain. When haptic sensory loss is
localized to a part of the body, or only certain components of touch sensation are missing, haptic stimulation
through wearable actuators at an alternative body part or using an alternative haptic modality has been proposed
to replace it. The goal of this project is to develop the specifications for wearable devices that act as haptic
sensory prostheses, laying the groundwork for later disease-specific implementation and testing.
We propose to (1) exploit attributes from both cutaneous and deep tissue sensation to communicate levels of
intensity of a signal, and (2) use new methods integrating 3D printed soft actuators with patterned knit enclosures
to enable wearable devices that can provide this stimulation. We will invoke spatial summation with larger
pressures resulting in deep tissue stimulation to increase the range of applied. A range of pressures and multiple
contacts on arm will act as a sensory substitute for missing, low-dimensional haptic sensation elsewhere in the
body. We will determine the feasibility and potential of this approach in two aims in both younger and older adults:
Aim 1: Identify appropriate pressure intensity range and resolution for multipoint contact pressure. We will
measure human perception of single and multipoint contact stimuli. The outcome of this aim will be a
characterization of the extent of spatial summation occurring for a range of pressure stimuli and a public dataset
for human perception of single and multipoint contact pressures at the stated locations.
Aim 2: Characterize the ability of humans to interpret two-degree-of-freedom information from a multipoint
contact pressure haptic sensory prosthesis. The outcome of this aim will be a measure of the effectiveness of
the deep pressure stimulation devices for improving the control of the arm position.
We intentionally scope this R21 proposal to test the highest-risk aspects of this methodology and develop data
that leads to future research and implementation to address diseases involving haptic sensory loss by our team
and others. Such future research includes the development of wearable haptic devices that meet the identified
specifications, characterizing the best type and location of haptic feedback to act as a sensory prosthesis, and
understanding and exploiting human adaptation to high-degree-of-freedom mappings between missing and
substituted haptic feedback.

Public health relevance
PROJECT NARRATIVE Amputation, diabetes, stroke, and a host of other diseases result in loss of touch sensation, affecting modalities including vibration, skin deformation, proprioception, temperature, and pain. We propose a sensory prosthesis to replace this lost sense of touch by providing touch feedback to other parts of the body. This work will collect new data and develop wearable take-home devices to improve quality of life for people with sensory loss.